ANALYSIS OF MEIOTIC CHROMOSOME SYNAPSIS IN YEAST

Meiosis is a fundamental process that sexually reproducing organisms undergo in order to reduce by half the chromosome number in germ cells. When meiosis fails, chromosomally imbalanced gametes result. In mammals the zygotes generated by fertilization of such chromosomally imbalanced gametes are inviable and account for a large number of spontaneous abortions. In cases where viable offspring are produced, mental and morphological defects such as those seen for Trisomy 21 or Turner syndrome (XO) are observed. Understanding how the meiotic process works to accurately segregate homologous chromosomes may ultimately provide the knowledge needed to monitor and prevent failures of this process. Proper segregation of homologs at Meiosis I requires that they first become physically associated by formation of a multi-protein structure called the synaptonemal complex (SC). The SC is formed by condensation of replicated pairs of sister chromatids along protein cores called axial elements (AEs) that are then synapsed by the insertion of a central region. Genetic studies in yeast have demonstrated that AEs are important for generating and packaging crossovers so that they ensure proper disjunction. Three key meiosis-specific components of yeast AEs are HOP1, RED1 and MEK1. Genetic experiments suggest that a balance between Hop1p/Red1p complexes and Red1p homo-oligomers is important for AE function and that this stoichiometry is regulated by the Mek1p kinase. The focus of this grant is to understand how AEs function in yeast by defining the specific roles of HOP1, RED1, and MEK1 during meiosis. Towards this end, a novel screen designed to isolate separation of function mutants in RED1 has been developed. This screen has already been successful in discovering an allele of RED1 that is specifically defective in binding to Hop1p. This mutant provides a useful tool to determine which meiotic processes require Red1p/Hop1 heterooligomers. Similar separation of function mutants will be sought in HOP1 and complementary experiments performed. The hypothesis that Hop1p homo-oligomers have a RED1-independent function in binding near the ends of meiotic double strand breaks will be tested using the chromatin immunoprecipitation technique. To understand how AE assembly is regulated, genetic and biochemical approaches will be used to identify the kinase responsible for activating Mek1p by phosphorylation of a conserved threonine.